Integrated, dynamic B0 and flip-angle shimming using multi-coil shim arrays

Project Summary/Abstract
7T MRI systems are installed worldwide more and more rapidly and are currently being evaluated in
clinics for a number of conditions such as detection of small focal cortical dysplasia, brain tumors and
multiple sclerosis (MS) lesions. However, the signal-to-noise and resolution advantage of 7T MRI is
counterbalanced by increased heterogeneity of the static B0 and transmit B1+ fields that degrade
image quality, which in turn slows clinical translation for example for patients with temporal lobe
epilepsy or MS lesions in the lower part of the brain/cerebellum. Parallel transmission (pTx) is a
popular solution to the problem of inhomogeneous B1+ but is costly (~$100k per transmit channel x 8
or 16 channels) and leads to complex specific absorption rate (SAR) management requiring lengthy
electromagnetic simulations that need to be validated. B0 field inhomogeneities close to the sinuses
and ear canals can be greatly reduced using multi-channel (MC) shim arrays that place dozens of
small loops close to the head and can be rapidly be switched on/off, thus allowing dynamic (slice-by-
slice) shimming which outperforms global brain shimming with conventional spherical harmonics shim
coils. Despite the potential of pTx and MC shim arrays, those state-of-the-art technologies are not
being quickly translated to the clinics because of the cost and complexity of combining and operating
them. In fact, most 7T systems currently operate in single channel mode with conventional spherical
harmonics shim coils, and therefore do not address head-on the dual problems of B0 and B1+ field
inhomogeneities, thus likely yielding sub-optimal image quality that may affect the perceived clinical
value of 7T MRI.
We propose a bioengineering research program leveraging the field control capability of
MC shim arrays to homogenize the flip-angle at 7T, thus yielding an integrated solution for B0
and flip-angle shimming that bypasses the need for pTx. We develop pulse design strategies that
use the degrees-of-freedom of MC shim arrays for flip-angle control while minimizing power
requirements and SAR. This includes general spokes and kT-point pulses where the gradient blips
are replaced by MC shim array blips with more general spatial distributions, as well as optimal control
of RF, gradient and MC shim current waveforms based on a direct optimization of Bloch dynamics.
We use those approaches to design “universal” pulses that can be played quickly without preparation.
We simulate and build an MC shim array integrated with the RF coil (“AC/DC” design) that is
optimized for simultaneous B0 and flip-angle shimming performance, which we evaluate in healthy
subjects and MS patients.

Public health relevance
Project Narrative 7T MRI image quality is degraded by inhomogeneities in the static B0 and transmit B1+ fields, which reduce its overall diagnostic value and slows its translation to clinics. The B0 and B1+ problems have so far been approached independently, thus yielding two separate hardware solutions, namely multi-coil (MC) shim arrays for B0 shimming and parallel transmission (pTx) for flip-angle control, that are expensive and difficult to integrate and operate. We propose a new class of excitation pulses that leverage the degrees-of-freedom of MC shim arrays to homogenize the flip-angle distribution at 7T, thus yielding an integrated solution for both B0 and flip-angle shimming that is cheaper and bypasses the complex safety management of pTx, and may therefore be more readily deployed in clinics.